ANRF 2025 Research Symposium

Project Summary | Arthritis and related autoimmune diseases are a major cause of pain, disability, and
decreased quality of life in the United States. This has motivated the Arthritis National Research Foundation
(ANRF) to fund interdisciplinary, early-career researchers working toward cures for these diseases. To further
our progress toward this goal, ANRF is requesting NIAMS and NIAID R13 funding to support the 4th annual
ANRF Research Symposium held March 14-15, 2025 at Northwestern University’s Feinberg School of
Medicine and Rush University in Chicago, IL. This event, helmed by Harris Perlman, MD, Ph.D. as PI, and a
committee of esteemed local researchers, is purposefully designed to elevate early-career scientists.
Researchers will share innovative research on arthritis and autoimmune diseases that spans immunology,
genetics, virology, bioinformatics, and clinical care. Participation in this symposium will broaden attendees’
scientific and clinical perspectives and expand their professional network through interactions with world-class
experts. The format of the symposium—based on highly successful iterations in past years and feedback from
prior attendees—will include research presentations from early-career scientists, a poster session, a keynote
address from a leading autoimmunity researcher, perspectives from patients with autoimmune diseases, and
an interactive career development workshop, led by key opinion leaders in the field of rheumatic disease. This
symposium is designed to accomplish three aims: (1) Provide a platform for the dissemination of innovative
research on osteoarthritis, rheumatoid arthritis, lupus, and other autoimmune diseases, (2) Promote career
development for early-career researchers, (3) Create opportunities for interactions between researchers from
different disciplines, institutions, and levels of experience to promote more innovative, collaborative work.
By accomplishing these aims, this symposium will advance science and clinical practice in arthritis and
autoimmune diseases, while simultaneously advancing the careers of the attendees. In doing so, the
symposium will directly support NIAMS and NIAID’s missions of supporting research to better understand
arthritis, musculoskeletal, and immunologic diseases, and training the researchers leading these
investigations.
This year's theme, "Beyond Boundaries: Pioneering Paths in Rheumatology Research," embodies a
commitment to pushing the limits of conventional thinking and charting new territories in the fight against
arthritis and autoimmune diseases. Through interdisciplinary dialogue, collaboration, and exploration, the
conference aims to activate innovation, uncover novel insights, and provide a platform for thought exchange.
These interactions will not only broaden attendees' scientific and clinical perspectives but also expand their
professional networks, laying the groundwork for future collaborations that hold the promise of transformative
discoveries.

Public health relevance
Project Narrative Early-career researchers in arthritis and related autoimmune diseases are carrying out critical research to meet the need for better diagnostic tools and treatments. The proposed ANRF Research Symposium will bring together early-career and established researchers to share research, interdisciplinary perspectives, and mentorship. This will help emerging researchers develop impactful and sustainable research programs, which will ultimately advance scientific knowledge about arthritis and autoimmune diseases.